BioAnalytical Chemistry Core

BIOANALYTICAL CHEMISTRY CORE – PROJECT SUMMARY
In the rapidly changing field of environmental health science, research needs are complex, requiring integration
of sophisticated bioanalyses including the ability to identify and quantitate trace metal speciation and
xenobiotic interactions with biomolecular targets. Performing these analyses requires highly trained personnel
with specialized expertise and access to advanced high-end equipment, beyond what is typically available in
most individual research laboratories. The BioAnalytical Chemistry Core (BACC) provides the NM-INSPIRES
Center investigators with the necessary expertise and tools for a variety of modern bioanalyses. Moreover, the
Core provides in-house analyses, supports innovative protocol development, and provides training to students,
fellows, and faculty in the integrated applications associated with the advanced analytical instrumentation
present in the facility. The Core additionally leverages access to several other existing on-campus core
facilities to enable innovative biomolecular methods and provides these services at subsidized pricing. Even
more important than access to the technology, the BACC provides tailored expertise to investigators to assist
in the design of molecular analyses and data interpretation to optimize the utilization of valuable biological
samples and resources. The facility will be managed by our Core leaders and knowledgeable staff scientists
with strong complementary expertise in bioanalysis and research facility administration. The Core equipment is
primarily housed in dedicated space in close proximity to most users. This centralization of resources and
knowledge provides consolidated and cost-effective bioanalytical services and technical expertise to the
Center members and users. The Core is organized into four units: Metals Analytical Chemistry, Oxidative
Stress, Environmental Mass Spectrometry, and Advanced Genomics. These complementary components
together will provide Center investigators with a continuum of bioanalytical capabilities for comprehensively
characterizing the response to environmental exposures and contaminants. The Specific Aims of this Core are
1) to provide consultation in the design, execution and interpretation of studies that require the use of
advanced analytical instrumentation for environmental research; 2) to develop and validate novel analytical
methods for detection and quantitation of environmental species in complex samples; and 3) to provide
education and training in analytical methods for environmental research through personal outreach, courses
and workshops, enabling the integration of cutting-edge analytical technologies into the research of NMINSPIRES
members. Overall, the BioAnalytical Chemistry Core will add considerable value to environmental
health research at the University of New Mexico by leveraging existing institutional and NIH investments in
research infrastructure to achieve the goals of our NM-INSPIRES research team.